GRABbing Serotonin During Fear

Serotonin plays a critical role in responding to potentially threatening stimuli and modulating the serotonin
system can either exacerbate or ameliorate fear responses to subsequent encounters with fear-producing
stimuli. Medications that inhibit serotonin reuptake are often used for stress disorders, but their effectiveness is
variable and may dissipate with time. As part of a P50 Conte Center project, we found that repeated
inescapable stress increased the expression of FKBP5 in mouse serotonin neurons using deep sequencing of
the serotonergic translatome. This gene encodes FKBP51, a protein that acts as a co-chaperone for steroid
receptors; its expression is dynamically regulated by complex physiological and epigenetic mechanisms, and it
is poised to play a critical role in modulating glucocorticoid feedback mechanisms that impair stress resilience.
We hypothesize that elevated FKBP5 expression in serotonin neurons interferes with hormonal feedback
mechanisms that are necessary for successful adaptation of the serotonin system to stress. There has been
scant research investigating the integration of steroid signaling with serotonergic function, and FKBP5 is
positioned to act as a key integrator of systemic stress hormones and serotonergic function. In Aim 1 we will
increase or decrease FKBP5 expression in serotonin neurons using intersectional strategies to investigate how
this FKBP51 modulates fear learning and extinction. In Aim 2 we will use the novel 5-HT biosensor GRAB5-HT3.0
to measure serotonin release in amygdala in response to optogenetic stimulation or during fear conditioning.
We have developed two novel Cre-dependent, conditional AAV vectors, one that expresses FKBP51 and GFP
(for overexpression), and the other that contains floxed and inverted SaCas9 and a FKBP5-specific guide
strand on separate transcriptional cassettes (for knockout). For Aim 1, we will inject these vectors into dorsal
raphe nucleus of Pet1-Cre mice for serotonin neuron-specific expression. We will investigate fear learning,
recall, extinction, and retrieval to investigate how high or low levels of FKBP5 in serotonin neurons affects
passive coping in response to fearful stimuli. In Aim 2 will also inject a novel GRAB fluorescent biosensor to
measure extracellular serotonin, which will be detected in response to graded optogenetic stimulation of the
serotonin fibers before and after fear conditioning and in response to cues. This will reveal the effects of high
or low levels of FKBP5 in serotonin neurons on serotonin release dynamics in amygdala. The results of these
innovative experiments will frame a larger R01 proposal to investigate the impact of FKBP5 and steroid
receptor signaling on serotonin neurons in a wider range of behaviors and brain regions and their potential role
in future therapeutics.

Public health relevance
Serotonin has dramatic effects on stress-related disorders such as posttraumatic stress disorder, and dysregulation of serotonin function is a major contributor to disease burden. We will test whether FKBP5, a key regulator of glucocorticoid stress hormone function, contributes to serotonin neuron dysfunction in a mouse model of fear learning and measure how high and low FKBP5 expression in serotonin neurons alters the physiology of and gene expression in serotonin neurons.